Role of multi-drug resistant Candida auris Hyr1 / Iff-like proteins in virulence and their potential as vaccine targets

MODIFIED PROJECT SUMMARY/ABSTRACT SECTION
Candidate: Dr. Shakti Singh is an accomplished immunologist, working as an Investigator at The Lundquist
Institute (TLI) and an Assistant Professor at the University of California, Los Angeles (UCLA). He has
demonstrated high research productivity throughout his training with over 20 peer-reviewed publications. This
K01 application outlines a career development plan to build professional competency and bridge technical gaps
in molecular biology, fungal pathogenesis, and vaccinology, with the objective of achieving full research
independence.
Mentors/Environment: Dr. Singh will be mentored by an interdisciplinary team with complementary expertise
in fungal pathogenesis, immunology, advanced vaccine technologies, and animal modeling. This interdisciplinary
mentorship is structured to provide high-level technical training in: 1) acquiring specialized expertise in advanced
fungal pathogenesis, molecular biology, and vaccinology; 2) developing advanced technical expertise and
project management skills; and 3) conducting high-impact biomedical research with rigorous ethical and
professional standards. The collaborative research environment and extensive resources and core research
facilities available at TLI, Harbor–UCLA Medical Center, and the UCLA provide an optimal setting for advanced
training and career development in infectious disease research.
Research: Candida auris is an emerging fungal pathogen responsible for life?threatening bloodstream infections
in immunocompromised patients, with mortality rates approaching 60%. C. auris readily colonizes healthcare
environments, forms multidrug?resistant biofilms on medical devices, and exhibits resistance to all major classes
of clinically available antifungal drugs. To address this unmet clinical need and decipher its virulence
mechanisms, we have identified three C. auris Hyr1/Iff?like (CAU?HIL) proteins that are conserved across all
known clades. Preliminary studies using monoclonal antibodies targeting conserved CAU?HIL epitopes
demonstrate partial protection against disseminated C. auris infection. However, the roles of CAU?HIL proteins
in virulence and their potential as vaccine/ immunotherapeutic antigens remain poorly defined. We hypothesize
that CAU?HIL proteins play critical roles in C. auris pathogenicity and represent superior immune targets
compared to antigens derived from other Candida species. Accordingly, this project will (1) investigate the
functional role of CAU-HIL proteins in C. auris virulence and (2) evaluate innovative CAU?HIL?based immune
strategies using clinically relevant in vivo infection models.

Public health relevance
PROJECT NARRATIVE Declared an “Urgent/Critical Threat” by both CDC and WHO, Candida auris infects immunosuppressed patients and is often untreatable due to resistance to all available antifungal drugs resulting in a high mortality rate of approximately 60%. We propose investigating the role of C. auris cell surface proteins in virulence mechanisms and developing novel vaccine strategies.